CANCER INFORMATION DISSEMINATION AND ANALYSIS CENTER

The objective of the Cancer Information Dissemination and Analysis Center (CIDAC) covering cancer diagnosis and therapy is to promote the exchange of technical information between cancer researchers on a world-wide basis by contributing to the active dissemination of research results in the area of cancer detection, diagnosis, staging, prognosis, treatment, and rehabilitation.